DEVELOPMENT&MANUFACTURE OF PHARMACEUTICAL PRODUCTS FOR THE TREATMENT OF SUBSTANCE ABUSE DISORDERS. NIDA REF. NO. N01DA-16-8926; POP: 09/18/2016 - 09/1

To carry out the development and manufacture of pharmaceutical preparations to be used in the medications development program of the National Institute on Drug Abuse (NIDA) for treating substance use disorders.